SKIN BIOPSIES FOR KERATINOCYTE CULTURE

We are studying responses of human cells to environmental stress. Skin biopsies are required to obtain samples of skin to initiate keratinocyte cultures or do immunohistochemical studies on skin sections.